Building the Hematopoietic Stem Cell Niche

DESCRIPTION (provided by applicant): A hierarchal and tightly controlled organization of various cell types is the hallmark of normal tissues and organs, and the hypothesis underlying this proposal is that pre-defining the specific location and resultant cell- cell interactions of individual cells within a 3D tissue construct will allow one to create highly functional tissues in which the role of cell-cell interactions on cell phenotype can be precisely delineated. This concept will be explored by developing a 3D model of human hematopoiesis, in which osteoprogenitors and vascular cells will be probed for their roles in defining the hematopoietic stem cell (HSC) niche. The specific aims include (1) the development of microfluidic techniques to allow large-scale encapsulation of single cells in highly defined extracellular matrix mimics in order to determine how matrix cues regulate mesenchymal stem cell differentiation at the single cell level, (2) the creation of hybrid integrated circuit/microfluidic circuit systems to enable one to assemble picoliter drops containing individual cells and synthetic ECM into 3D assemblies with pre-defined structure and organization, and (3) determining whether appropriate in vitro assembly of HSCs and cells representative of the bone marrow HSC niche can yield functional hematopoietic tissues capable of recreating hematopoiesis in vitro. Success in this project will lead to the creation of a new set of tools that will enable formation of 3D tissues with precisely defined cell placement, and homotypic and heterotypic cell-cell interactions. These tools are likely to be broadly useful to the creation of new in vitro models of tissue development and drug screening, and in vivo tissue replacements from a variety of cell types. As stem cells are particularly sensitive to environmental cues, inappropriate cell-cell and cell-matrix interactions likely lead to the irreversible and undesirable alterations in stem cell differentiation fate found in culture. The systems developed in this project will allow us to investigate the specific role of vascular cells and osteoprogenitors/osteoblasts in maintaining the human HSC niche, which is a difficult question to address in vivo. It is crucial to better define and create models of the niche to understand normal hematopoiesis and pathologies involving blood cells, and to enable hematopoiesis on demand in various therapeutic venues. The key studies to date on this topic have relied on rodent models, and the relevance of many findings to human biology is currently unclear. (End of Reviewers' Comment)

Public health relevance
PROJECT NARRATIVE The production of blood cells (hematopoiesis) is a continuous, critical activity of stem cell in the body, and its dysregulation has severe repercussions. This project will lead to a better understanding of this process by developing new culture models of human hematopoiesis, and it is expected these models will provide insight on current therapies using blood stem cells, could lead to the production of human blood cells that could be used to treat patients, and may also improve our understanding of diseases involving blood cell production. __SpecificAimsTextDelimiter__ Specific Aims 3D cell assemblies are increasingly being utilized to both provide new models for in vitro drug screening, and as in vivo replacements for damaged tissues and organs. Further, these tissue mimics are likely to provide a crucial complement to current systems used to model human biology, which are predominantly based on 2D culture of human cells, and animal models of tissue and organ function. However, in spite of the hierarchal and tightly controlled organization of various cell types that is the hallmark of normal tissues and organs, most 3D cell culture systems instead start with clusters of cells or a random assembly of cells, and the premise that the originally random cells have the capability to appropriately self-organize over time. The hypothesis underlying this proposal is that pre-defining the specific location and cell-cell interactions of individual cells within a 3-D tissue construct will allow one to create highly functional tissues in which the role of cell-cell interactions on cell phenotype can be precisely delineated. This concept will be specifically explored in the context of creating 3D model of hematopoiesis, in which mesenchymal stem cells (MSCs) and other cells of the osteoblast lineage, and vascular cells have been hypothesized to play a key role in the hematopoietic stem cell (HSC) niche. The tools developed in this project will be used to precisely define cell-cell interactions of HSCs with osteoprogenitor/osteoblasts and vascular cells, and define the role of these interactions in a model of the human HSC niche. Specific Aims: 1. Develop microfluidic techniques to allow large-scale encapsulation of single cells in highly defined extracellular matrix mimics, and determine how matrix cues regulate mesenchymal stem cell differentiation at the single cell level. Sub-hypothesis: the ability to manipulate single cells, along with the matrix with which they associate is essential to building 3D tissues with highly defined cell-cell and cell-ECM interactions and organization. 2. Design hybrid integrated circuit/microfluidic circuit systems to enable one to assemble picoliter drops containing individual cells and synthetic ECM into 3D assemblies with pre-defined structure and organization. Sub-hypothesis: integrated circuit technology provides an appropriate platform to manipulate single cells +/- associated matrix into artificial tissues with precisely defined homotypic and heterotypic cell interactions. 3. Determine whether appropriate in vitro assembly of HSCs and cells representative of the bone marrow HSC niche can yield functional hematopoietic tissues capable of recreating hematopoiesis in vitro. Sub-hypothesis: development of an appropriate niche for human HSCs that enables in vitro reconstitution of hematopoiesis can be achieved by appropriate 3D interactions with osteoprogenitors and/or vascular cells in assembled tissue mimics. Success in this project will lead to the creation of a new set of tools that will enable formation of 3D tissues with precisely defined cell placement, and homotypic and heterotypic cell-cell interactions. These tools are likely to be broadly useful to the creation of new in vitro models of tissue development and drug screening, and in vivo tissue replacements from a variety of cell types. As stem cells are particularly sensitive to environmental cues, inappropriate cell-cell and cell-matrix interactions likely lead to the irreversible and undesirable alterations in stem cell differentiation fate found in culture. The systems developed in this project will allow us to investigate the specific role of vascular cells and osteoprogenitors/osteoblasts in maintaining the human HSC niche, which is a difficult question to address in vivo. It is crucial to better define and create models of the niche to understand normal hematopoiesis and pathologies involving blood cells, and to enable hematopoiesis on demand in various therapeutic venues. The key studies to date on this topic have relied on rodent models, and the relevance of many findings to human biology is currently unclear.